Wireless Wearable with AI Analytics for Monitoring Neonatal Abstinence Syndrome (NAS)

PROJECT SUMMARY
Neonatal abstinence syndrome (NAS) is an opioid withdrawal syndrome that develops shortly after birth to in
utero-exposed neonates. Newborns with NAS typically receive care in the Neonatal Intensive Care Unit
(NICU), where the daily cost of care is high, costing $2.5 billion per the 22,000 infants born with NAS and an
average cost of $79 937.75 per baby annually [47]. Although there are medication-based interventions for the
treatment of NAS, which are used in up to 80% of opioid-exposed infants, these treatments carry their own
risks of toxicity and drug interactions [48]. Despite the steep medical costs and the risks of treatment, current
tools to assess the severity of NAS are subjective and suffer from examiner bias, resulting in poorer clinical
outcomes, such as longer lengths of stay in the NICU, for these babies [4]. There is an urgent need for
innovative new methods to reliably diagnose NAS and thoroughly assess the efficacy of responses to
treatment.
Rekovar has worked diligently to develop Neomonki (Neonatal Monitoring Kit), a simple economical solution to
objectively assess and treat NAS. Neomonki is an affordable, wearable monitoring device that continuously
reports measures of behavioral and physiological symptoms correlating to NAS that may otherwise go
unnoticed to healthcare professionals. Neomonki consists of wireless wearable wristbands fitted with biosensor
technology, a tablet fitted with Rekovar’s healthcare portal enhanced with robust encryption/data collection
capabilities, a charging dock station which powers the tablet and allows easy access to recharge the
wristbands, a camera attached to the dock station to analyze imaging properties, and a portable cart which
holds the dock station and allows for easy repositioning of Neomonki. Neomonki will revolutionize neonatal
healthcare with a cutting-edge AI (Artificial Intelligence) clinical algorithm that analyzes biosensor and imaging
data to deliver predictive NAS analytics and enhance diagnostic decision-making. Rekovar has successfully
pursued several objectives to enhance the performance of Neomonki, including size reduction and improved
functionality and safety features. Rekovar has also made strides in improving Neomonki’s software graphical
user interface, ensuring that it is user-friendly and functional. However, the device's success depends on the
development of the AI algorithm for assessing patient symptoms and prescribing appropriate treatments.
This proposal revolves around the collection of data in clinical trials to develop, optimize, and refine an
algorithm for assessing NAS symptoms in neonatal patients with the Neomonki. This will be done in two
phases: i) the initial data collection and publication on the advantages of continuous monitoring in NAS
neonates using Neomonki, the development of an AI algorithm to automate symptom scoring with high
accuracy, and the preparation for an FDA De Novo submission for the Neomonki wearable. And ii) validating
the AI algorithm through a second clinical trial, conducting a pilot study to establish the Neomonki device's
effectiveness in improving clinical outcomes, expanding the AI algorithm to include FNASS scoring with high
accuracy, and achieving FDA De Novo approval for the Neomonki system. These clinical trials will compare the
performance of Neomonki against the currents standards of care used by participating hospitals. A key
milestone of this stage of the project is to assess whether the optimized automated digital scoring and
suggested treatment algorithm can improve clinical outcomes, shorten hospital stays, and decrease daily
costs. Achieving this milestone will allow Neomonki to be used commercially to automate digital assessments
and treat patients.

Public health relevance
PROJECT NARRATIVE Rekovar is developing Neomonki (Neonatal Monitoring Kit), a low-cost wearable monitoring system that integrates wirelessly with a mobile device to allow real-time monitoring of a baby’s physical and physiological state while undergoing neonatal abstinence syndrome (NAS). With an AI (Artificial Intelligence) automated scoring system and continuous data collection, Neomonki provides more accurate and consistent scores for Finnegan Neonatal Abstinence Scoring System (FNASS) and Eat Sleep Console (ESC), which will lead to decreased length of stay, unbiased treatment information, and improved clinical outcomes for the babies. The increased accuracy in monitoring NAS allows for better assessment of the neonate's condition, and more timely and appropriate medication adjustments, without exhausting options for treatment prematurely, and easing staffing burden on monitoring and treating this demanding condition. The development of Neomonki can revolutionize the treatment of NAS and positively impact countless lives.